Safety, tolerability, and feasibility of empagliflozin therapy in dialysis-dependent ESKD

PROJECT ABSTRACT
Cardiovascular (CV) disease is the leading cause of mortality in end-stage kidney disease (ESKD),
accounting for 55% of total deaths. In particular, sudden cardiac death poses the greatest threat to the
dialysis population. A diagnosis of heart failure (HF), a highly prevalent complication that is associated with
an 80% mortality rate within three years in chronic dialysis patients, is a powerful predictor of sudden death
in ESKD. A clustering of metabolic and myocardial abnormalities, including insulin resistance, impaired
myocardial bioenergetics, left ventricular hypertrophy (LVH), myocardial fibrosis, and diastolic dysfunction,
mediates development of HF and increases the risk of sudden death in ESKD. Regrettably, therapeutic
options to ameliorate the CV risk remain very limited in ESKD. Development of novel and effective
interventions to reduce HF risk and death, therefore, represents one of the greatest unmet needs for the
dialysis population. Sodium-glucose cotransporter 2 inhibitors (SGLT2is), a novel class of oral hypoglycemic
medications that reduce glucose reabsorption in the renal proximal tubule, have recently demonstrated
unprecedented efficacy to reduce HF hospitalization and CV deaths in patients with and without type 2
diabetes. Emerging data suggest that the benefits of SGLT2is include their efficacy to mitigate insulin
resistance, enhance mitochondrial oxidative capacity in the heart, reverse LVH and improve diastolic
dysfunction, and reduce cardiac fibrosis. Given that these CV benefits are hypothesized to be downstream
consequences of renal SGLT2 inhibition (i.e. glycosuria and natriuresis), clinical trials have excluded those
with advanced renal failure. There is compelling evidence, however, that SGLT2is may have direct effects
on myocardium, independent of its action on the kidney, to restore myocardial electrophysiologic balance,
enhance mitochondrial function, and reduce fibrosis, with a potential to reverse LVH and prevent HF and
arrhythmia. These data raise a crucial question if SGLT2is may improve survival in ESKD. In order to
perform a full-scale clinical trial to evaluate the CV and survival benefits of SGLT2is in ESKD, a pilot study is
required to assess preliminary safety, tolerability, and feasibility. We hence propose a randomized, double-
blind, placebo-controlled, 3-arm pilot study in 75 chronic hemodialysis participants to evaluate (1) safety and
tolerability of empagliflozin, a selective SGLT2 inhibitor, including a steady-state pharmacokinetic (PK) study
of two different daily doses and (2) feasibility of conducting a full-scale clinical trial. Our proposal is the first
study to evaluate safety and tolerability of a SGLT2i in ESKD to date, including a detailed PK study of two
doses to examine the effect of chronic administration. Positive findings will (1) provide the necessary
preliminary safety, tolerability, and feasibility data to plan a larger, multi-center clinical trial in ESKD, and (2)
promote future studies to investigate the efficacy of SGLT2is to provide myocardial and metabolic benefits,
which may lead to a paradigm shift in the management of CV risk in ESKD.

Public health relevance
PROJECT NARRATIVE Empagliflozin, a novel diabetic medication that targets the kidney, has recently been shown to improve cardiovascular survival in diabetic and non-diabetic patients with minimal to moderate kidney dysfunction. We will examine if empagliflozin is safe in patients with end-stage kidney disease on chronic dialysis. If our study shows that empagliflozin is safe and is well tolerated in dialysis patients, it will encourage future studies to evaluate its efficacy to reduce heart failure risk and improve survival in dialysis patients and provide a new potential therapeutic option.